Structural Cell Biology of DNA Repair Machines

DESCRIPTION (provided by applicant): We are studying the structural organization of DNA repair complexes that excise DNA damage and the functional consequences of disrupting these protein-protein interactions by mutation and small molecule inhibitors. Alternative pathways of repair are available for many types of DNA damage, and posttranslational modifications generated in response to DNA damage control the differential assembly of repair complexes, providing a mechanism for regulating pathway choice. Cancer-associated defects in DNA maintenance activities can be exploited therapeutically by targeting the remaining repair activities with mechanism-based inhibitors. Our work focuses on the mechanisms of repairing DNA single strand breaks generated by the base excision and nucleotide excision repair pathways. We are studying the physical assembly of DNA damage excision complexes in vitro and in cultured cells, and the mechanism of coupling DNA cleavage to end processing and ligation. Small angle x-ray scattering of purified DNA repair complexes reveals dynamic conformational states that we propose are important for handoffs of DNA repair intermediates to successive enzymes in a pathway. High resolution crystal structures and small molecule screening experiments are being used to predict and identify inhibitors of repair protein interactions, which are candidates for anti-tumor therapies and serve as reversible chemical probes of cellular physiology during DNA damage responses. This integrated approach takes advantage of the broad expertise of investigators in Projects 1, 2, and 6 for assays and biological materials, as well as the unique capabilities of the Expression and Molecular Biology Core and the Structural Cell Biology Core of the SBDR Program to produce proteins and structurally evaluate repair complexes.

Public health relevance
RELEVANCE: The Achilles' heel of all cancer cells is their defect in DNA repair and cell cycle checkpoints that can kill tumor cells by causing them to enter cell division before repair is complete. Thus, many cancers are treated by radiation and chemotherapies to overload repair in tumor cells but not in normal cells, which are better protected by redundant repair pathways and functioning cell cycle checkpoints. SBDR will comprehensively characterize DNA repair circuits to reveal tumor vulnerabilities that are key to short-circuiting DNA repair and specifically killing cancer cells while not harming better-protected normal cells.